Identification of Host-Specific Determinants of APOL1-associated COVAN

ABSTRACT
Coronavirus disease 2019 (COVID-19)-associated nephropathy (COVAN) is a severe form of kidney disease
resulting from collapse of the glomerular tuft and manifesting clinically with proteinuria and high rates of kidney
failure. More than 90% of COVAN cases are associated with two coding variants in the apolipoprotein L1
(APOL1) gene. These variants are mainly found in persons with Black, African American, or Hispanic ancestry.
The objective of this proposal is to identify patient-specific determinants of APOL1-mediated COVAN
penetrance. Our published and preliminary data suggest that: 1. APOL1 is robustly expressed in the glomeruli
of patients with COVAN but not in healthy controls. 2. COVID-19-induced cytokines upregulate pathogenic
APOL1 variants via JAK-STAT signaling in human kidney organoids and, in turn, cause podocyte injury. 3.
Cytokine-induced podocyte injury is blocked by inhibition of JAK/STAT/APOL1 axis. 4. Expression of variant
APOL1 protein is sufficient to cause dose-dependent cytotoxicity in vitro. Consistent with these discoveries,
others found that expression of APOL1 variants caused glomerulosclerosis in transgenic mice. Based on these
published and preliminary data, we hypothesize that maladaptive crosstalk between glomerular cells and
immune cells drive increased expression of APOL1 and the pathogenesis of COVAN. Moreover, that patients
who develop COVAN either express higher levels of pathogenic cytokines (those cytokines known to induce
APOL1 expression), or the glomerular cells of these individuals have an enhanced and maladaptive response
to the same level of cytokine. To test this hypothesis, we will leverage unique patient-derived kidney organoids
and immune cells of persons with biopsy-proven COVAN (collected after patients have recovered from
infection). We propose two aims: 1.) Delineate the divergent biological responses of kidney organoids derived
from COVAN patients versus controls after (i) infection with SARS-CoV-2 or (ii) treatment with COVID-19
induced cytokines. 2.) Identify differences in cellular response of immune cells of COVAN patients versus
controls after (i) infection with SARS-CoV2 or (ii) treatment with COVID-19 induced cytokines. Identifying host-
factors that regulate APOL1 and immune-glomerular interactions in COVAN will provide novel biomarkers and
therapeutic targets for modulating APOL1 expression to treat COVAN and other forms of APOL1 nephropathy,
helping to mitigate disparities in kidney disease. Execution of these scientific aims and completion of the career
development activities of this proposal, along with the experienced mentorship and strong institutional support,
will prepare me for a career as an independent physician scientist equipped for research into APOL1-
mediated, inflammatory-mediated, and viral-mediated nephropathies.

Public health relevance
PROJECT NARRATIVE Nearly all cases of COVID-19-associated nephropathy (COVAN) occur in persons with high-risk apolipoprotein L1 (APOL1) genotype, resulting in significant morbidity and mortality and a disproportionate burden of kidney disease on persons of West African descent. This study aims to identify host factors that regulate APOL1 and immune-glomerular interactions in COVAN, providing novel biomarkers and therapeutic targets. Improved understanding of the host factors that effect COVAN penetrance and development of targeted therapeutics are critical to mitigating the racial disparities caused by COVAN in COVID-19 related health outcomes and other forms of APOL1 nephropathy.